Super Greedy Trees

Project Summary/Abstract
We identify critical weaknesses with Classiﬁcation and Regression Trees (CART), a widely used base learner
for machine learning of big omic-data analysis, and propose to replace these with a fundamentally different type
of base learner we call super greedy trees (SGT's). SGT's cut the space in a fundamentally different manner,
resulting in a richer partition structure with provable consistency and superior empirical performance. The project
will develop a uniﬁed SGT framework for big data analysis using machine learning including the treatment of time
varying covariate survival analysis, unsupervised learning, highly imbalanced data and multivariate regression.
The SGT framework will be deployed within scalable and extensible open source software that will allow NIGMS
researchers to deploy them to deal with their challenging big data problems.

Public health relevance
Project Narrative We develop a comprehensive framework and scalable open source software for machine learning of big omic-data using super greedy tree base learners.